Core C: Administrative Services

PROJECT SUMMARY / ABSTRACT – Core C
The purpose of this core is to facilitate communication between the investigators, collaborators, and advisors of
the Program Project, and to provide oversight for all scientific activities, including routine assessment of progress
toward the Program’s specific aims. This effort includes organizing the regular meetings of the investigators and
advisors of the Program Project. The Administrative Core provides financial management and oversight of
compliance with NIH regulations, as well as general administrative services, for all research projects and core
units of the Program Project.